Mechanisms of Neural Synchrony in the Medial Entorhinal Cortex

Project Summary
The medial entorhinal cortex (mEC) plays a vital role in spatial navigation, learning, and
memory. Many neurons in layer II/III of the mEC exhibit spatially tuned firing rates that generate
a grid-like (‘grid cells’) pattern when traversing an open field. Grid cell firing rates are modulated
by a theta (4-12 Hz) frequency, network-wide oscillation generated via input from the medial
septum. Further, higher frequency gamma (40-140 Hz) oscillations are nested within the slower-
wave theta oscillation and are believed to help synchronize grid cell spike output. Several
studies have demonstrated that grid cells are largely connected through a dense network of
fast-spiking interneurons which are critical for the generation of gamma oscillations. However,
the functional network connectivity between putative grid cells and fast-spiking interneurons in
the mEC, which generate theta-nested oscillations during spatial navigation, are not fully
understood. Whole-cell patch clamp recordings remain the standard for measuring intracellular
membrane voltage and current, but this technique has relatively low throughput. Recent
advances in fluorescent voltage indicators have enabled the imaging of both action potentials
and subthreshold activity from tens of neurons during optogenetic stimulation. We propose
utilizing the sensitivity of whole-cell voltage clamp recordings to capture network synaptic
activity in stellate, pyramidal and fast-spiking interneurons during optogenetic stimulation of
different local excitatory and inhibitory cell populations. Following this, we will determine the
spike timing of excitatory and inhibitory neurons relative to theta-nested gamma oscillations in
the local field potential by imaging intracellular voltage in a densely labeled population during
optogenetic stimulation of local excitatory neurons. The combination of these techniques will
establish the functional input/output of each cell type necessary for developing and testing
potential canonical models of grid cell activity and network synchrony during spatial navigation.
The proposed research will be conducted at Boston University in the Rajen Center for
Integrated Life Sciences which is home to a multidisciplinary community of neuroscience
investigators. This institute combines experts from the Center for Systems Neuroscience and
the Neurophotonics Center which fosters a diverse collaborative environment to tackle
challenging research projects. Further, the development of my academic training, technical
skills, scientific communication, professional skills, and consistent mentorship will ensure the
success of this project.

Public health relevance
Narrative Neural circuits in the medial entorhinal cortex are critical for spatial navigation, learning, and memory. The completion of this project will provide mechanistic insight into how excitatory and inhibitory neurons in layer II/III mEC synchronize to generate theta-nested gamma oscillations observed during spatial navigation. A map of functional connectivity as well as the extent of recurrent excitation and inhibition between stellate, pyramidal, and fast-spiking interneurons, will provide a foundation for developing accurate models of spatially tuned neurons and grid cell formation.